Targeted Death of Collagen1a1-Expressing Fibroblasts Reduces Silica-Induced Pulmonary Fibrosis

PROJECT SUMMARY
A key feature of progressive fibrotic diseases of the lungs, including in patients with silicosis, is the excessive
deposition of scar tissue and extracellular matrix (ECM), particularly collagen1a1 (Col1a1). Fibroblasts are
known to be resistant to apoptosis and persist in fibrotic lungs, continuing to lay down matrix, contributing to a
progressive and persistent phenotype in patients. Fibroblasts that participate in this pathogenic process have
most commonly been identified by αSMA staining and termed myofibroblasts. However, recent work by our group
and others has shown that αSMA does not identify all pathogenic fibroblasts in pulmonary fibrosis. This proposal
seeks to address the central hypothesis that elimination of persistent collagen-producing fibroblasts is critical in
halting disease progression. Based on our robust preliminary studies, we propose three specific aims to test this
central hypothesis. Specific Aim 1 will determine the accumulation and localization of Col1a1+ fibroblasts to the
fibrosis associated after silica exposure using a lineage tracing strategy. We hypothesize that Col1a1+ fibroblasts
accumulate and persist in mouse lungs during silica-induced pulmonary fibrosis. In Aims 2 and 3 we ask if the
loss of Col1a1+ fibroblasts prevents fibrosis progression. Specific Aim 2 will test the hypothesis that the
progression of silica-induced pulmonary fibrosis in mice is arrested after the selective and targeted ablation of
Col1a1+ fibroblasts. Specific Aim 3 will test the hypothesis that genetic loss of the anti-apoptotic protein Bcl-2 in
Col1a1+ fibroblasts promotes their susceptibility to undergo intrinsic apoptosis during silica-induced pulmonary
fibrosis resulting in the arrest of disease progression. There are currently no FDA approved therapies for silicosis
and no therapies that stop or reverse fibrosis for pulmonary fibrosis in general. Thus, there is a critical need to
identify molecular pathways or cell populations that are targetable for therapeutic intervention. Additionally, the
proposed studies will provide a novel and mechanistic understanding about pathogenic fibroblast accumulation
and persistence in driving the progression of silica-induced pulmonary fibrosis.

Public health relevance
Project Narrative Pathogenic collagen-producing fibroblasts accumulate and persist at sites of fibrosis in progressive silica- associated pulmonary fibrosis. We hypothesize that targeted removal of collagen1a1-expressing fibroblasts through genetic ablation or sensitization to apoptosis after Bcl-2 knockdown will reduce fibrosis in a silica-induced progressive fibrosis mouse model. The results of our studies should provide insight into the dependence of fibrosis progression on Col1a1-expressing fibroblasts and development of novel therapeutic strategies to stop fibrosis progression that will improve the outcomes for patients with silica-induced fibrotic lung disease; as there are currently no FDA approved therapies.